Novel proteolytic mechanisms driving pathologic hepatic congestion in drug-induced hepatotoxicity

Modified Project Summary/Abstract Section
The summary/abstract did not require alteration
The leading cause of acute liver injury and acute liver failure in the United States is hepatotoxicity caused by overdose of the pain medication acetaminophen (APAP). Even with available treatments (i.e., N-acetylcysteine), more than half of APAP overdose patients require costly hospitalization and antiquated standards to guide treatment. APAP overdose patients would benefit most from treatments that prevent the progression of simple hepatotoxicity to liver failure. Using robust experimental settings and results from acute liver failure patients, our team uncovered a novel pathway whereby macrophage elastase (MMP-12) prevents progression of hepatotoxicity to ALF by reducing excess production of the fibrinolytic enzyme plasmin. The current view is that plasmin production in the APAP-injured liver is controlled by standard proteins involved in blood clot lysis. However, our strong preliminary studies suggest that, in contrast to the current paradigm, hepatic plasmin generation is controlled locally by direct MMP-12-dependent proteolysis of the plasminogen zymogen. The central hypothesis framing these studies is macrophage elastase (MMP-12) prevents vascular damage and intrahepatic congestion after APAP overdose by cleaving plasminogen at a site that releases the anti-inflammatory factor angiostatin while preventing formation of active plasmin. Our approach includes genetically-modified mice with deficiency in components of the signaling pathway controlling MMP-12 expression, mice expressing plasminogen with an active site mutation that prevents plasmin activity, novel lipid nanoparticles to superimpose plasminogen deficiency in experimental APAP hepatotoxicity, and leading edge N-degradomics to pinpoint plasmin substrates in the injured liver. The established investigative team comprises experts in APAP-induced liver injury and repair, biochemistry/function of the fibrinolytic system, vascular pathology, leading-edge proteomic analysis, and experimental settings of liver disease. In our proposed studies we will: define the cellular and molecular mechanisms driving MMP-12 expression after acetaminophen overdose (Aim 1); determine the mechanisms whereby MMP-12 prevents pathologic vascular congestion in the acetaminophen-injured liver (Aim 2); and determine the role of plasmin(ogen) proteolytic and non-proteolytic functions in APAP-induced liver injury (Aim 3). The expected outcome of these Specific Aims is the discovery of a novel mechanistic link between leukocyte effector function (i.e., MMP-12 expression) and prevention of intrahepatic hyperfibrinolysis in the injured liver, including evidence of a novel molecular mechanism controlling plasmin generation. This could pinpoint mechanistic biomarkers to predict imminent hepatic vascular dysfunction in the injured liver and to uncover therapeutic modalities to prevent hepatic congestion after hepatotoxicant exposure. By virtue of separation from traditional regulation of fibrinolysis, this could greatly improve outcome in APAP overdose without increasing bleeding risk.

Public health relevance
PROJECT NARRATIVE Overdose of the commonly used analgesic drug acetaminophen is a leading cause of liver toxicity and liver failure, in part because there have been no major advances in specific treatments to prevent progression of hepatotoxicity to acute liver failure. Acute liver injury is associated with activation of a blood clot degrading enzyme called plasmin, and prior studies suggest plasmin promotes blood vessel damage in the liver that causes acute liver failure and its most severe consequences. The primary goal of this research program is to uncover how plasmin activity is controlled in the injured liver, such that new therapies can be designed to prevent morbidity and mortality in patients with liver toxicity.